SCI Consortium Study: Neural Stem Cell Transplantation for Cervical Spinal Cord Injury

Spinal cord injury (SCI) often damages, not only white matter axon tracts that transmits signals to and
from the brain, but also the central gray matter, causing segmental loss of interneurons and motor
neurons. Transplantation of neural stem cells (NSCs) has the potential to replace lost neurons and
glia. These transplanted neurons can form functional relays between spinal segments disconnected
by the injury. We have generated human NSCs with a spinal cord identity to test the hypothesis that
spinal cord NSCs will more appropriately integrate into sites of the injured spinal cord. Our
preliminary data provide evidence that both rat and human neural stem cells can be transplanted into
multiple models of SCI, including a clinically relevant contusion model. However, humans NSCs
appear to develop on a longer timeline, more similar to human development. Therefore, we aim to
characterize the maturation and phenotype of human spinal cord NSCs (scNSCs). Long-term studies
will assess the efficacy, safety and synaptic integration of such scNSC therapy in a clinically
relevant contusive model of cervical SCI.
This work is highly innovative and clinically oriented:
1) We will utilize a contusion type injury that is most applicable to human SCI.
2) We will examine a novel human NSC line with a spinal cord identity (scNSCs).
3) Long-term studies will examine the maturation, efficacy and safety of scNSCs, our lead cell
candidate, for the treatment of spinal cord injury.
4) Novel trans-synaptic tracing techniques will be used to assess the synaptic integration of both host
inputs to the graft and graft outputs to host motor neurons.

Public health relevance
There are more than 42,000 veterans among 288,00 Americans living with SCI today, and treatments to repair the injured spinal cord do not exist. This research project aims to develop neural stem cell therapies to repair the injured spinal cord by forming new neural relays across sites of even severe injury. We will study a promising human neural stem cell line to determine its long-term safety and efficacy after SCI in animal models. !